Boston University Clinical and Translational Science Institute

Contact PD/PI: CENTER, DAVID M. ABSTRACT: NOT APPLICABLE FOR THIS COMPONENT Project Summary/Abstract Page 151 Contact PD/PI: CENTER, DAVID M.

Public health relevance
PROJECT NARRATIVE: NOT APPLICABLE FOR THIS COMPONENT Project Narrative Page 152